EFFECTS OF GCSF AND DEXAMETHASONE ON BLOOD NEUTROPHIL COUNTS IN NORMAL SUBJECTS

The purpose of this study is to determine the best way to collect the largest number of neutrophils with the least chance of bothersome side effects to the donor of cells.